Targeting Pathogenic Endothelial Dysfunction in Lupus Nephritis

Systemic lupus erythematosus (SLE) is an immune complex-mediated disease in which clinical disease
manifests after an innate immune response. Endothelial cells (EC) are conditional effector cells activated by
inflammatory stimuli to produce intracellular reactive oxygen species (ROS) and signal for influx of inflammatory
cells into tissue. We have published that endothelial nitric oxide synthase (eNOS) modulates inflammation in
lupus nephritis (LN) and that uncoupling of EC eNOS (which reduces production of anti-inflammatory nitric oxide
(NO) and increases production of pro-inflammatory ROS) is a potential therapeutic target in SLE. We hypothesize
that sepiapterin, a compound that couples eNOS, will improve LN outcomes and vascular function in murine LN
and work by modulating the PI3Kinase/Akt pathway to reduce expression of inflammation and fibrosis genes in
mice and in cultured glomerular endothelial cells. We further hypothesize that the proposed approach may have
off target effects, particularly in T cells, monocyte/macrophages, and podocytes. To address this overarching
hypothesis, the following specific aims are proposed: Specific Aim 1) Determine the effect of sepiapterin in
murine LN on clinical and histologic LN outcomes, large vessel endothelial function, and
pharmacodynamic markers of treatment response. We hypothesize that sepiapterin will improve LN
outcomes and vascular function in murine LN. To determine the effect of and optimal therapeutic indication for
ECD targeted therapy, we will use the NZM2410 model of spontaneous LN and compare groups with and without
sepiapterin treatment to determine effect on three different endpoints. 1) preventing/prolonging LN onset with
sepiapterin monotherapy, 2) in mycophenolate-treated mice, improving/hastening induction of remission with
sepiapterin as an adjunctive therapy, and 3) after inducing remission, prolonging/preventing LN flare with
sepiapterin monotherapy after mycophenolate withdrawal. LN clinical and histologic parameters and large vessel
endothelial function will be the primary endpoints. Biomarkers of systemic oxidative stress will serve as
exploratory pharmacodynamic indicators. Specific Aim 2. Determine differential gene expression and
phosphokinase signaling events, with a focus on the PI3K/Akt pathway, induced in human glomerular
endothelial cells (HRGECs) by LN serum and modulated by sepiapterin. Based on our published and
preliminary studies, we hypothesize that inflammatory gene expression and PDGF receptor/PI3K/Akt/FoxO1
signaling induced by LN flare serum can be modulated by sepiapterin in HRGECs. Knowledge of pathways
activated by LN flare serum that both initiate redox-regulated pathways and that can be modulated by restoring
coupling to eNOS will be important for rational development of therapies to target ECD in LN. We will culture
HRGECs with serum from SLE patients with active nephritis or a cytokine mix and perturb signaling through the
PDGFR, PI3K, and Akt to determine the effect on gene expression and NO and superoxide production. Specific
Aim 3. Determine differential inflammatory and fibrosis gene expression and pathway enrichment in
endothelial cells, infiltrating inflammatory cells, and podocytes from renal glomerular tissue and in T
cells from the spleen in mice treated with increasing doses of sepiapterin. Based on our published and
preliminary studies, we hypothesize that candidate PI3K-Akt signaling gene enrichment (both potentiated by and
inducing of oxidative stress in a feed forward fashion) will be modulated by sepiapterin. NZM2410 mice will be
treated with increasing doses of sepiapterin and renal cortical and spleen tissue analyzed by single cell RNA
sequencing. The ultimate goal of our translational group is to target ECD to improve cardiovascular and renal
outcomes in LN. Given the prevalence of cardiovascular disease in LN, we will study endothelium-dependent
vascular function to inform early human studies of cardiovascular prevention. The aims proposed here will
demonstrate the most effective treatment indications, pharmacodynamic markers of response, and alternate or
adjunctive targets to reduce inflammatory ECD in LN and other diseases of endothelial dysfunction in Veterans.

Public health relevance
Systemic lupus erythematosus (SLE) patients suffer from heart attacks at rates well above the general population. Heart disease results in part from abnormal function of endothelial cells that prevent artery clogging cholesterol plaques from forming. Half of SLE patients also develop kidney disease that can lead to kidney failure. We propose a paradigm shift to focus on endothelial cell dysfunction as a mediator of inflammation in the kidney as well as in heart disease. Based on the results of the prior funding period, we will test the effectiveness of a medicine that restores endothelial function (sepiapterin) to treat lupus-like kidney disease and improve endothelial function in mice with lupus kidney disease. We will study its ability to prevent kidney disease, induce remission of kidney disease along with standard treatment, and maintain remission after withdrawal of the standard medication. We will study alternative ways that endothelial dysfunction occurs and how sepiapterin works to improve outcomes to inform future human studies.